Pharmacokinetic Study of Human Complement Factor H Antibody GT103 in Mice Period of Performance: 5/21/2018 - 12/31/18 Task Order Type: Firm Fixed Price

Pharmacokinetic Study of Human Complement Factor H Antibody GT103 in Mice